Pilot And Feasibility Program

PROJECT SUMMARY – PILOT AND FEASIBILITY PROGRAM
The Pilot and Feasibility Program (P/F) of the Colorado NORC program allows investigators to explore the
feasibility of their research ideas and collect sufficient preliminary data to compete successfully for federal
funding from the NIH, disease specific sources or foundations. The P/F program is primarily designed for
young investigators who desire to pursue a career in nutrition research. While we do not exclude applications
from more established investigators who propose to move into the area of nutrition research or to explore new
directions within nutrition research, these applications are typically reviewed less favorably. The P/F
program offers a $40,000 award over a two-year period. The Colorado NORC provides funding for pilot and
feasibility projects for investigators who meet one of the
following:
1. New investigators with a project relevant to Nutrition who have no independent NIH (or
comparable) funding
2. Established investigators with a project relevant to Nutrition who have not previously worked
in the field of nutrition
3. Established nutrition investigators who propose a project significantly different from previous
Over the past 20 years we have funded 39 pilot projects. Of those who have completed their projects, 92% are
still in obesity/nutrition research, 74% remain in our research base, and 65% have been successful in securing
independent research funding. The P/F program has been one of the most successful parts of the Colorado
NORC.